Molecular Mechanisms of Inner Ear Function

Project Summary / Abstract The sensory receptors of the inner ear, the hair cells, mediate our senses of hearing and balance because of their ability to convert mechanical forces into electrical signals. This process happens in the mechanosensitive organelle, the hair bundle, which protrudes from the cell's apical surface. The hair bundle is composed of a few tens to hundreds of actin-rich stereocilia that are arranged in a hexagonal array. Mechanical deflection of the bundle toward the tallest stereocilia leads to shearing motions between adjacent stereocilia that are exerted by tip links, connectors between the tips of shorter stereocilia with its taller neighbor. The consequential increase of mechanical tension in the transduction apparatus increases the open probability of mechanically gated ion channels located at or near the tips of stereocilia, resulting in an influx of cations that depolarizes the hair cell, thereby generating a receptor potential. The understanding of hair bundle development, maintenance, and ultimately the molecular basis of its function, is fundamental for inner ear biology and also for our understanding of human hearing loss and disequilibrium. One aim of this proposal is to investigate the molecular basis of stereocilia height regulation by investigating the consequences of loss of the gene encoding twinfilin 2, a protein that is located near the tips of stereocilia. For this purpose, we will employ transgenic mouse technology, quantitative 3-dimensional microscopic analyses using confocal and electron microscopy, as well as electrophysiology. A second aim focuses on the role of a group of TRP proteins including members of the TRPML and TRPV subfamily that appear to be able to form heteromeric ion channels in hair cells. We hypothesize testing whether these heteromeric channels are functional, and whether they play a role in hair cell function. Particularly, we are interested in exploring a role of TRPML/TRPV heteromers in mechanoelectrical transduction. Analyses include biochemical, electrophysiological, and cell- based assays, as well as transgenic mice, histology, whole animal auditory function tests, and electrophysiology.

Public health relevance
Project Narrative In this grant application, it is proposed to investigate the role of twinfilin 2, a newly identified hair bundle protein, in hair bundle development and in mature hair cells. In an independent aim, it is proposed to test whether TRPML3 and the related TRP channels TRPML2, TRPV5, and TRPV6 play important roles in hair cells or other inner ear cell types. Both topics are being pursued using transgenic mouse technology, high- resolution imaging, and electrophysiology. Understanding hair bundle development and the functional role of specific ion channels in inner ear cell types is fundamental for inner ear biology and also for our understanding of human hearing loss and disequilibrium. __SpecificAimsTextDelimiter__ Specific Aims This proposal aims to elucidate the function of the novel stereociliary protein twinfilin 2, and to continue our investigation of TRP ion channels, particularly we focus on the role of TRPML2/3 and TRPV5/6 in hair cells. SA1: Function of Twinfilin 2. The barbed end capping protein twinfilin 2 appears near the tips of short and middle rows of mouse cochlear stereocilia just at the onset of a neonatal stereocilia elongation phase from postnatal day (P) 5 - P15. Whereas short and middle row stereocilia do not elongate during this period, the tall rows that are devoid of twinfilin 2 nearly double in length. Overexpression of twinfilin 2 in CL4 cells and inner hair cells results in shorter microvilli and stereocilia, respectively. Here we propose investigating the effects of loss of twinfilin 2 function by generating a conditional knockout in mice. We propose testing two hypotheses: first, we will investigate whether loss of twinfilin 2 function controls the final phase of stereocilia growth in neonatal cochlear hair cells. Secondly, in adult hair cells, we will test whether disruption of the twinfilin 2 gene affects the properties of the mechanoelectrical transduction apparatus by modulating the actin cytoskeleton near the tips of short and middle row stereocilia, the place where functional mechanoelectrical transduction channels are located. To achieve these goals, we will first (SA1A) generate and validate mice with conditional Twf2 gene inactivation, and then use these mice (SA1B) to test the two described hypotheses. SA2: Role of TRPML2/3 and TRPV5/6 channels in hair cells. Based on a severe hair cell phenotype in varitint-waddler mice and based on immunolocalization in wild type mice, we contend that cochlear hair cells express TRPML3. Conditional and ubiquitous inactivation of the Trpml3 gene, however, does not cause an inner ear phenotype, which led us to hypothesize that TRPML3 is a dispensable subunit of native heteromeric ion channels. We further hypothesize that these native channels are comprised of TRPML2/TRPML3 and TRPV5/TRPV6 subunits, and that individual TRPML as well as the TRPV subunits are redundant. We have accumulated a battery of pilot data supporting this hypothesis, including protein interaction studies, preliminary evidence that TRPML3 interacts with the lower tip link component Pcdh15, as well as results with TRPML3 agonists suggesting that native TRPML3-containing heteromeric channels exist. In SA2A, we hypothesize that TRPML2/3 and TRPV5/6 form functional heteromeric ion channels. Using novel TRPML3 and TRPML2-specific agonists as well as dominant-negative isoforms, we will test the ability of TRPML2/3 and TRPV5/6 to form functional heteromers. Specifically, we will determine channel properties with calcium imaging and whole cell patch clamp recordings. Analysis of outside-out patches will be utilized to unequivocally obtain single channel features, which will be compared with known features of native rodent hair cell channels such as the mechanoelectrical transduction channel. SA2B addresses the hypothesis that TRPML3-containing heteromeric channels are essential for hair cell function. TRPML2, TRPML3, TRPV5, and TRPV6 are expressed by hair cells. We hypothesize that single knockouts of either gene may not display strong phenotypes because of compensation and natural redundancy. This is already confirmed for Trpml3, Trpv5 and Trpv6 knockouts. Double knockouts of both Trpml or both Trpv genes are not doable by simple crossing of mutant animals because of the genomic tandem configuration of the genes. To address this conundrum, we will generate a conditional double knockout for TRPML2 and 3, now making use of the tandem configuration of both genes. Existing single TRPV5 and TRPV6 knockouts will be used to investigate hair cell function in mice that lack three of the four ion channels. With this strategy, we hypothesize that potential compensation is eliminated, which should reveal an essential function of TRPML2/3 and TRPV5/6 in sensory hair cells. In SA2C, we pursue a different strategy for circumventing TRP channel redundancy and compensation. We have preliminary results showing that a dominant-negative (DN) TRPML3 isoform is able to inactivate a presumably heteromeric native channel expressed in skin melanocytes that can be activated by 5-mesityl-3- oxa-4-azatricyclo[5.2.1.0~2,6~]dec-4-ene, a compound identified in a high-throughput screen for TRPML3 activators. We hypothesize that knock-in mice expressing this dominant-negative gene (Trpml3DN) will show a more severe phenotype than Trpml3 knockout mice because the dominant-negative TRPML3 subunit will inactivate heteromeric channels that would be unaffected in a knockout because of redundancies. Analyses will include whole animal physiology (ABR and DPOAE analyses), inner ear histology including hair cell cytomorphology, as well as electrophysiological interrogation of hair cell features including mechanoelectrical transduction and characteristics of voltage-dependent hair cell currents.